US Census Project

Agreement between the National Cancer Institute and the U.S. Census Bureau through which the U.S. Census Bureau will provide the NCI with data from the 2000 and 2010 Censuses showing modified race by Hispanic origin by age and sex at the Census tract level.